Impact of Universal Free Meals on Childhood Obesity Risk and Obesity Disparities

ABSTRACT
Childhood obesity is highly prevalent, difficult to treat and prevent, and of major health and economic
consequence. Lower income children and children of Black, Latinx, and Native American race/ethnicity
experience a disproportionate burden of obesity as compared to higher income and White or Asian children.
Evidence suggests that economic and environmental factors, many driven by structural racism, underlie racial
and income disparities in obesity. These structural factors are often acknowledged as potential root causes of
obesity and obesity disparities; however, they are also recognized as difficult to intervene upon. Policy
interventions are one option for affecting change upon these potential root causes. Using a natural experiment
approach, we have an opportunity to leverage a recent policy change—the Community Eligibility Provision (CEP)
of the Healthy Hunger-Free Kids Act of 2010—to assess the degree to which providing free meals to all children
in high poverty schools affects obesity prevalence. The CEP was passed in 2010 and allows schools in high-
poverty school districts to provide universal free meals (breakfast and lunch) to all children in the school without
requiring individuals to sign up for the free and reduced lunch program. The goal is to increase participation in
school meals and ultimately reduce both food insecurity and obesity. The program is targeted at lower- and
lower-middle income children, many of whom were not receiving free- and reduced-price lunches despite being
eligible. Because the CEP is targeted to high-poverty schools, focuses on a social determinant (income
constraints) and is a non-agentic policy (i.e. children and their families do not need to do anything extra to receive
the benefits), this policy has high theoretical potential to decrease obesity and possibly decrease obesity
disparities. CEP could be expected to impact child body weight by prompting individuals to substitute healthier
foods for unhealthier food and by providing two meals a day at no cost, thus affecting child BMI through indirect
pathways of increased disposable household income. This increase in disposable income could lead to
decreased food insecurity, decrease parental stress, and/or could potentially be used for health promoting
behaviors, such physical activity or purchasing of healthier foods in the household, each of which has been
associated with obesity. CEP represents a significant change in school policy and an expansion of social safety
nets, but scant scientific literature exists on the health impacts of CEP. The proposed study aims to
comprehensively assess the impacts of CEP on obesity outcomes through using robust data and methods for
causal inference in order to assess: 1) the impact of CEP on obesity 2) impact of CEP on potential mediating
mechanisms 3) heterogeneities in impacts on obesity by race/ethnicity and income 4) impacts on population-
level obesity disparities.

Public health relevance
PROJECT NARRATIVE This study will assess the impact of a major change to school food policy—the Community Eligibility Provision—which allows high-poverty schools to provide free meals to all children regardless of individual income. We will assess whether the universal free meals under this policy impact child obesity and obesity disparities.